Biodesign for Health Equity

SUMMARY/ABSTRACT
We seek to establish a summer experiential learning (EL) program for undergraduate biomedical engineering
(BME) students that focuses on health equity education through Biodesign immersion. The Biodesign process
is a systematic approach for the identification of unmet medical needs, the generation of novel technologies to
address them, and the development of commercialization plans to bring them into fruition (i.e., identify, invent,
and implement). We plan to capture key elements of these three phases through a unique EL framework that
combines needs identification with parallel research and development (R&D) activities on distinct projects. The
Specific Aims include: (1) rural and urban clinical immersion and needs identification; (2) parallel R&D
component to support a later-stage technology; (3) assessment of healthcare advancement metrics and
professional development by exploring the growth of the students' Engineering Habits of Mind (EHoM). The
proposed program is a strategic partnership between Virginia Tech (VT) and Carilion Clinic, an integrated
healthcare system in Southwest Virginia with a variety of rural and urban healthcare environments. The
improvement of health outcomes among rural patients is more intractable and provides fertile ground for
innovation. In the clinical immersion, teams will apply contextual inquiry methods with mentors in the
departments of surgery and nursing to identify design opportunities and develop EHoM in systems thinking and
problem finding. Preparation will include training on user-centered research methods, such as task analyses
for identifying stakeholder "pain points." The teams will plan and document their design research at the clinical
sites to create a database of >25 needs with supporting information related to stakeholders, existing solutions,
regulation, reimbursement, market, and the Social Determinants of Health (SDoH). Students will prepare a
product development plan on a design opportunity well-suited to improve patient care and promote health
equity. They will then recruit and lead a future senior design team to solve the associated challenge. The
concurrent R&D component of the program captures a majority of the EHoM through the signature design
pedagogy. Teams will be assigned to existing projects R&D projects at Carilion Innovation (Cl}, a specialized
technology transfer and invention development group for Carilion's internal providers. Students will carry
projects through reduction-to-practice and proof-of-concept testing at the Carilion Clinic Center for Simulation,
Research, and Patients Safety (CSRPS). Utilizing assigned projects will give students added exposure to
tinkering, verification and validation, fabrication technologies, and manufacturing. Building this knowledge base
will feed back into the clinical immersion component as an additional set of lenses for filtering needs. Further,
multitasking on needs identification and parallel R&D will prepare students to manage different sets of
deliverables and timelines in their future careers. Taken together, this program will offer a deep-dive into best
practices associated with identifying medical needs and serve as a career bridge for students planning to enter
the medical device industry.

Public health relevance
NARRATIVE We are developing a new training program for biomedical engineering (BME) students that will cultivate their Engineering Habits of Mind (EHoM) and serve as a bridge to a career in medical device research and development (R&D). This experiential learning (EL) opportunity will consist of a clinical immersion conducted in rural and urban healthcare facilities to identify unmet medical needs with a focus on understanding the social determinants of health (SDoH) and promoting health equity. In parallel, student teams will build prototyping skills by working on existing R&D projects to improve healthcare with our clinical partner and lead design, fabrication, and proof-of-concept testing through simulated use verification and validation activities.